Molecular Dissection of Mitochondria-Organelle Interactions

ABSTRACT
This is a request for an administrative supplement for NIH DP2ES032761 titled “Molecular Dissection of
Mitochondria-Organelle Interactions”. This project aims to identify the signals that originate from other
organelles and regulate mitochondria in healthy cells and target them in mitochondrial dysfunction for
therapeutic gain, using an innovative mitochondrial labelling and isolation strategy coupled to imaging. In this
supplement, we propose to determine how of mitochondria-organelle interactions change in cellular models of
mitochondrial diseases, using high resolution imaging techniques and biochemical methods. This
administrative supplement will provide an outstanding co-mentored training experience of an underrepresented
minority baccalaureate degree holder, Francisco Miralles, whose career goal is to continue his education in an
MD/Ph.D program.

Public health relevance
PROJECT NARRATIVE Mitochondrial dysfunction is a common underlying feature of many neurodegenerative and metabolic diseases, including inherited mitochondrial diseases, Parkinson’s disease, type 2 diabetes. Mitochondria-organelle interactions regulate important mitochondrial functions, but how these interactions change in diseases is not well understood, and their therapeutic potential has not been explored. A systematic characterization of mitochondria- organelle interactions in cellular models of mitochondrial diseases may uncover novel mechanisms of disease associated mitochondrial dysfunction.